Liver lobule zonation, hepatocellular carcinoma (HCC) and β-catenin mediated hepatitis B virus (HBV) biosynthesis

Project Summary and Relevance.
Hepatitis B virus (HBV) infection is a worldwide health problem. It is estimated that there
are 200 to 500 million HBV chronic carriers in the world for whom, to date, there is no
reliable treatment. HBV causes both acute and chronic liver disease and is responsible
for an estimated one million deaths annually from liver cirrhosis and primary hepatocellular
carcinoma (HCC). Currently available therapies reduce viral loads but fail to resolve
chronic HBV infections and hence require lifelong treatment. A major obstacle to the
resolution of chronic HBV infections is the limited number of HBV targets that are suitable
for the development of antiviral therapies. All the current antiviral therapies target the HBV
reverse transcriptase/DNA polymerase, often leading to the development of drug-resistant
variants. Curative therapies will require the identification of additional antiviral targets.
Cellular gene products that make a significant contribution to HBV biosynthesis represent
potential additional antiviral targets which alone or in combination with current HBV
reverse transcriptase inhibitors may represent a potential curative therapy. One potential
cellular gene target that might represent an HBV antiviral target is β-catenin, the terminal
mediator of the Wnt/β-catenin signal transduction pathway which can be inhibited by the
FDA-approved drug, Pyrvinium. Preliminary data indicate that β-catenin can activated
HBV transcription and replication in cell culture and β-catenin activity correlates with viral
biosynthesis in vivo in the HBV transgenic mouse model of chronic viral infection.
Consequently, cell culture analysis will be performed to define the molecular mechanisms
mediating β-catenin enhanced HBV transcription and replication. Characterization of
inducible liver-specific β-catenin-null and APC-null (β-catenin activated) HBV transgenic
mice will indicate the in vivo contribution of β-catenin to the restricted localization of viral
biosynthesis to pericentral hepatocytes within the liver lobule and restricted viral
expression within HCC tissue. Furthermore, treatment of HBV replicating cells and
transgenic mice with Pyrvinium will indicate if an available FDA approved drug can
modulate the Wnt/β-catenin signal transduction pathway and act as an antiviral therapy.
Defining the role of the Wnt/β-catenin signal transduction pathway in determining the level
of HBV biosynthesis may lead to the identification of cellular therapeutic targets that are
amenable to the further development of novel modalities to resolve rather than simply treat
chronic HBV infection.

Public health relevance
Project Narrative Hepatitis B virus (HBV) is a major human pathogen that replicates by reverse transcription of its pregenomic RNA within the viral capsid. HBV pregenomic RNA levels are regulated by the transcriptional coactivator, β-catenin, which also contributes to liver lobule zonation and hepatocellular carcinoma development. A detailed understanding of the mechanism by which β- catenin contributes to viral biosynthesis, hepatocyte metabolism and liver tumor initiation may permit the development of more effective antiviral and cancer therapies targeting the Wnt/β- catenin signal transduction pathway.